Leadership and Organizational Change Learning Network Hub Site

National efforts to increase implementation of innovative and evidence-based practices in VA mental health
systems have been disappointing. Studies have identified a number of barriers to their implementation,
including organization-level barriers and lack of leadership support. There is a need for implementation
strategies to foster strong leadership for organizational change, to support VA’s strategic priorities to improve
leadership competence and to function as a Learning Healthcare System. The Leadership and Organizational
Change for Implementation (LOCI) is an implementation strategy that trains and works with leaders across
organizational levels to improve organizational climate and promote activities associated with improved care.
LOCI was adapted specifically for VA with input from a group of partners from the Office of Mental Health and
Suicide Prevention VISN and facility mental health leads, as well as therapists and leaders from VA mental
health settings, and considerable demand has been expressed for bringing LOCI into the VA. The Learning
Network Hub will have two key goals: (1) to successfully implement a Train the Training (TTT) Program to build
capacity to train and support LOCI and (2) to implement the LOCI training program within VA to support the
uptake and increased reach of evidence-based practices and interventions (EBPs). To build internal capacity
to conduct LOCI training, by Year 3, the LOCI developers will use a “see one, do one, teach one” approach,
supplemented with simulation, to train and develop VA LOCI trainers and coaches. In Year 1 the initial group of
5 VA LOCI trainers and coaches will observe the LOCI developers lead a workshop (“see one”) and will co-
lead the post-training coaching for the first cohort of 12 VA program leaders (from 6 facilities). During this first
year, LOCI materials will continue to be refined for the VA, with a goal to have a fully developed training
manual for trainers and an updated coaching manual. These activities will serve to: 1) train and prepare LOCI
facilitators within the VA system, 2) pilot and refine LOCI in VA mental health programs, and 3) identify and
prepare potential future LOCI coaches among the first facilities and programs. Year 2 will focus on conducting
LOCI workshops and coaching with VA program leaders and expanding coaching capacity. VA trainers will
lead the LOCI workshops and coaching for the next wave of VA Mental Health Program Leads (“do one”), with
observation, support, and fidelity assessment from LOCI developers. The original 5 VA coaches will train an
additional 3 coaches with guidance from the LOCI developers. Sixteen VA employees/program leads in 8
facilities will participate in the LOCI training program. Year 3 will focus on achieving independence from the
LOCI developers and promoting further spread. VA LOCI facilitators will lead the LOCI workshops with support
and LOCI fidelity assessment from the LOCI developers. The VA LOCI Trainers who were trained in Year 1 will
train an additional 7 coaches, who will co-lead coaching calls with them. At the end of Year 3, 5 VA LOCI
trainers/coaches and at least 10 additional LOCI coaches will be fully trained and 68 VA mental health program
leaders will have completed the LOCI training program as they change organizational context to improve the
reach and quality of evidence-based practices and Gold Status Programs at their facilities. Additional
mentoring will be provided to Gold Status Fellows and research teams that implement LOCI to support
important VA initiatives. The Hub will also provide online LOCI tools and resources with a message on a
Teams site. Mixed methods will be used to evaluate the Hub’s impacts on program levels of implementation
leadership, implementation climate, and use of practices that reflect scientific evidence and delivery system
priorities. The Learning Network Hub team includes the LOCI developers and VA investigators with expertise in
implementation science, effectiveness research, health services, organizational change, and mixed methods
program evaluation. It supports key VA strategic priorities, including functioning as a Learning Healthcare
System, increasing leadership competence, and access to evidence-based mental health care.

Public health relevance
A number of mental health interventions are effective, but they are underused in the VA, meaning that Veterans may not receive the most effective care possible. Leadership support and organizational functioning are key factors in whether or not evidence-based practices are used in healthcare settings. The purpose of the proposed QUERI Learning Network Hub is to build capacity to deploy and spread an implementation strategy designed to improve organizational leadership to increase the use of evidence-based practices in VA mental health. It will be the first implementation strategy that explicitly focuses on leadership and organizational change in VA mental health. By building capacity for LOCI within VA, the LOCI Hub supports the VA priorities of modernizing systems and focusing resources more efficiently by training, supporting, and motivating leaders to promote the use of evidence-based interventions for veterans. Ultimately, the Hub aims to improve Veteran experience, care quality, and mental health outcomes, all key priorities for VA. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page